Short-term and long-term intervention effects on distress, cognitive functioning, and inflammation in older women with breast cancer

PROJECT SUMMARY
Background and Significance. An estimated 75% of women diagnosed with breast cancer (BCa) who receive
treatment experience cancer-related cognitive impairment (CRCI)1,2. Further, the presence of CRCI in the
subsequent months or years after treatment remains present in up to 35% of these women2. One important
modifiable factor, psychological distress, has been shown to be associated with CRCI in women with BCa2,5,
and dysregulation in immune functioning (e.g., inflammation) has similarly been linked to CRCI in this
population2,18, however, the mechanisms involved are still not well understood6. Given that the majority of
women diagnosed with BCa transition into survivorship22, it is imperative to understand how BCa exacerbates
cognitive decline for older women, particularly in the context of normal aging. Previous research has examined
interventions, such as cognitive behavioral therapy (CBT)8,9 and relaxation training10,11 for improving cognitive
functioning, but none have tested the effectiveness of an intervention that encompasses both of these
elements. Cognitive-behavioral stress management (CBSM) is an empirically validated 10-week group-based
intervention that blends CBT and relaxation training and has been shown to be efficacious in reducing distress
(e.g., decreased negative affect, depression, and anxiety)12,13 and pro-inflammatory markers14, and in
improving QoL13,15 among women with BCa. This work has evolved to the development and testing of
remotely-delivered (R-CBSM) interventions, which have been shown to be feasible and acceptable in this
population. Research Strategy. The proposed study aims to 1) assess the efficacy of the R-CBSM intervention
on subjective cognitive functioning in older women with BCa, 2) examine specific mediators (e.g., inflammation
and distress) of R-CBSM intervention effects on cognitive functioning, 3) examine the mediating effects of
perceived stress management skills (PSMS) on distress and inflammation, and 4) associate the effects of the
R-CBSM intervention-related changes in distress and inflammation with longer-term (36-72 months) subjective
and objective cognitive functioning. Training Plan. Expanding my knowledge base and competencies in areas
including quantitative analytic skills, psycho-oncology, aging, and cognitive functioning in cancer populations, in
addition to enhancing professional development and research dissemination skills (including presentations and
publications), will help me achieve my long-term goal to become an independent researcher in the field of
health psychology. Overall, I aspire to explore the underlying mechanisms of patient distress to better inform,
develop, and implement scalable interventions for improving biopsychosocial health outcomes (e.g., cognitive
functioning) for patients with cancer and other chronic conditions.

Public health relevance
PROJECT NARRATIVE Cancer-related cognitive impairment (CRCI) has often been linked to negative side effects of treatment (e.g., chemotherapy), however many women with breast cancer (BCa) experience CRCI regardless of treatment status. Prior research has pointed to psychological distress and dysregulation in immune functioning (e.g., inflammation) as key predictors of CRCI in women with BCa, suggesting that these are modifiable factors that can be targeted to improve cognitive functioning in this population. The proposed project aims to elucidate the underlying mechanisms of CRCI and to examine the short- and long-term benefits of a remotely-delivered cognitive-behavioral stress management (R-CBSM) intervention on CRCI in distressed older women with BCa, ultimately to improve their quality of life during treatment and through survivorship.